Image-guided Biocuration of Disease Pathways From Scientific Literature

Realization of precision medicine ideas requires an unprecedented rapid pace of translation of biomedical
discoveries into clinical practice. However, while many non-canonical disease pathways and uncommon drug
actions, which are of vital importance for understanding individual patient-specific disease pathways, are
accumulated in the literature, most are not organized in databases. Currently, such knowledge is curated
manually or semi-automatically in a very limited scope. Meanwhile, the volume of biomedical information in
PubMed (currently 28 million publications) keeps growing by more than a million articles per year, which
demands more efficient and effective biocuration approaches.
To address this challenge, a novel biocuration method for automatic extraction of disease pathways from
figures and text of biomedical articles will be developed.
Specific Aim 1: To develop focused benchmark sets of articles to assess the performance of the biocuration
pipeline.
Specific Aim 2: To develop a method for extraction of components of disease pathways from articles’ figures
based on deep-learning techniques.
Specific Aim 3: To develop a method for reconstruction of disease-specific pathways through enrichment
and through graph neural network (GNN) approaches.
Specific Aim 4: To conduct a comprehensive evaluation of the pipeline.
The overarching goal of this project is to develop a computer-based automatic biocuration ecosystem for
rapid transformation of free-text biomedical literature into a machine-processable format for medical
applications.
The overall impact of the proposed project will be to significantly improve health outcomes in
individualized patient cases by efficiently bringing the latest biomedical discoveries into a precision
medicine setting. It will especially benefit cancer patients for which up-to-date knowledge of newly
discovered molecular mechanisms and drug actions is critical.

Public health relevance
The overall impact of the proposed project will be to significantly improve health outcomes in individualized patient cases by efficiently bringing the latest biomedical discoveries into a precision medicine setting. In this project, a novel biocuration method for an automatic extraction of disease mechanisms from figures and text in scientific literature will be developed. These mechanisms will be stored in a database for further querying to assist in medical diagnosis and treatment.